Basic Science Core

PROJECT SUMMARY (BASIC SCIENCE CORE)
Developing new drugs, vaccines, and diagnostics to combat the TB epidemic requires increased
understanding of Mycobacterium tuberculosis pathogenesis. Achieving these goals will require an influx of new
investigators trained in basic and advanced TB methods, as well as access to highly specialized facilities and
equipment. The primary goal of the Basic Science Core is to provide the consultation and training necessary to
equip investigators with the expertise and tools needed to advance the field. The Basic Science Core will focus
on new investigators (NIs) at the start of their careers and more established scientists who are new to TB
research. We will utilize the outstanding TB research facilities and equipment within Seattle, and leverage the
complementary expertise of SEA-TRAC investigators at the University of Washington, Seattle Children’s
Research Institute, and the Fred Hutchinson Cancer Research Center.
In Aim 1, we will provide basic training to new investigators who seek access to the BSL3 to initiate new
TB research programs. Our curriculum will be split into: Tier 1 -- basic BSL3 work with a dedicated BSL3 trainer;
and Tier 2 -- hands-on, specialized training for either microbiology-focused or immunology-focused work. In Aim
2, we will provide a consultation service for new TB investigators with an interest in studying Mtb microbiology.
We will advise regarding the best-suited approaches and technologies to address their specific pathogen-related
research questions. Drawing from the broad expertise and resources of the Seattle TB research community, and
working with the Development Core Pilot Program, we will also provide opportunities for in-depth training in a
diverse suite of standard and advanced approaches to study Mtb biology. In Aim 3, we will develop a parallel
program to the one in Aim 2, for new TB investigators with an interest in Mtb immunology. We will provide a
consultation service to match the best-suited advanced approaches to address Mtb immunology research
questions. We will also provide in-depth training in a broad range of cutting-edge technologies that target
understanding the host response to Mtb. Altogether, these efforts will equip the next generation of TB
investigators with the skills to generate scientific insights and help end the TB epidemic.